The functional organization of mammalian membranes

PROJECT SUMMARY
Our laboratory investigates the functional organization of mammalian membranes to generate mechanistic
insight into the connections between lipid composition, membrane structure, and cell physiology. Membranes
host a major fraction of all cellular bioactivity, orchestrating myriad simultaneous, parallel tasks. This
functionality is enabled by the remarkable complexity and diversity of mammalian lipidomes, which give rise to
a unique combination of biophysical phenotypes, including membrane fluidity, tension, curvature, and lateral
compartmentalization. We aim for a predictive understanding of how lipidomic features determine membrane
properties, and how these in turn regulate cell functions. Progress towards this goal has been enabled by
recent methodological advances in high-throughput lipidomics, biophysical analysis of plasma membranes,
and quantitative high-resolution spectral microscopy. Using these, we have made significant advances in
understanding several interrelated aspects of lateral and transverse organization of mammalian membranes.
We have defined broad structural features responsible for protein association with ordered membrane domains
and how such domains are involved in membrane traffic. Despite these insights, there remains remarkably little
known about which proteins associate with membrane domains and why. Our experimental and computational
framework allows us to address key outstanding questions, including: what are the structural codes for protein
affinity for ordered domains, and how does protein association with membrane domains facilitate their
localization and function? In parallel, we have characterized the remarkable plasticity of mammalian
membranes (particularly their susceptibility to dietary fatty acids) and characterized the effects of external
inputs on membrane properties and cell function. However, how cells maintain membrane homeostasis in
response to continuous challenge from dietary and other external inputs is not well understood. Our
observations suggest that interference with such homeostatic mechanisms may provide a novel therapeutic
strategy for treatment of cardiovascular disease or cancer. Finally, our most recent work has focused on the
asymmetric distribution of lipids between the two leaflets of the plasma membrane bilayer. Although such
compositional asymmetry appears to be a universal design principle for living membranes, the selective
advantages that asymmetry confers are not known. We are defining the compositional, biophysical, and
functional asymmetry of the plasma membrane in mammalian cells to answer major open questions about the
biophysical consequences of membrane asymmetry and how physical properties are coupled across
asymmetric leaflets. Functionally, intriguing recent discoveries reveal that transient loss of membrane
asymmetry is widespread during immune activation, and is necessary for optimal response; however, the
mechanisms underlying these effects of transient lipid scrambling are unknown. Addressing these questions
will advance our understanding of the functional role of membrane organization across the tree of life.

Public health relevance
Project Narrative (Public Health Relevance) The membranes of mammalian cells have complex compositions that are required for their unique structure and vast array of functions. The research in our laboratory is focused on defining the diversity of mammalian membrane compositions and how those lipids are organized to facilitate cellular physiology. The insights from work are expected to inform therapeutic strategies for diseases associated with membrane dysfunction, including cardiovascular disease and cancer.